Control of HIV-induced MDSC expansion and immunosuppression by cytotoxic lymphocytes

Elevated frequencies of granulocytic myeloid-derived suppressor cells (PMN-MDSCs) precede and contribute to
immune dysfunction in persons living with HIV (PLHIV). The underlying mechanisms of this dysregulation are
poorly understood. Potential mechanisms under investigation include PMN-MDSCs impacting CD4+ T cell
recovery, expanding T-regulatory cells (T-reg), inducing immune checkpoints (IC), and suppressing the antiviral
functions of cytotoxic lymphocytes. While the initiation of combined antiretroviral therapy (cART) can reduce
peripheral blood PMN-MDSCs levels in PLHIV, PMN-MDSCs levels can remain elevated despite cART, and
cART does not remedy all PMN-MDSC-induced immune dysfunction. The tumor-necrosis-factor-related-
apoptosis-inducing-ligand (TRAIL) is a cell-surface and secreted apoptosis-inducing protein expressed by
activated human Natural Killer (NK) cells and cytotoxic T lymphocytes (CD8+ T cells, CTL). TRAIL ligation of its
receptors (also called death receptors (DRs)) induces apoptosis on DR-expressing cells. PMN-MDSCs express
TRAIL-R1 (DR4) and 2 (DR5). Recently published work showed a link between serum levels of agonistic soluble
TRAIL (sTRAIL) and PMN-MDSC frequency in PLHIV. Early in HIV infection, PMN-MDSC frequency inversely
correlates with plasma levels of sTRAIL, and recombinant TRAIL induces PMN-MDSC apoptosis in vitro. Thus,
DR ligation, currently being explored as an immunotherapy for cancer, may be a way to reduce PMN-MDSCs
frequencies in PLHIV. In addition to TRAIL, PMN-MDSCs also express NKG2D-ligands. NKG2D is an NK cell
activating receptor and a positive costimulatory receptor of human CTLs, and NKG2D-ligand expression renders
PMN-MDSCs highly susceptible to NK cell killing. However, despite data implicating PMN-MDSCs as essential
contributors to immune dysfunction and HIV disease, approaches targeting PMN-MDSCs in PLHIV have yet to
be explored. Using a mouse model with a competent and HIV susceptible humanized immune system, we found
that PMN-MDSCs expand rapidly upon HIV infection. Like in humans, PMN-MDSCs correlated positively with
HIV viral titers and T-reg in this model. Mechanistic studies in cytotoxic lymphocyte-depleted animals revealed
that NK cells and perhaps also CTLs controlled PMN-MDSC expansion, expressed NKG2D, and upregulated
TRAIL upon HIV infection. We propose to explore the mechanisms by which PMN-MDSC and consequent Treg
expansions are controlled. We propose to test the hypothesis that therapeutic PMN-MDSCs reduction during
HIV infection prevents PMN-MDSCs-caused immune dysfunction, improving viral control. Our studies will
leverage novel tools and therapeutic approaches to define the impact of the TRAIL and NKG2D pathways on
controlling PMN-MDSC and resultant Treg expansion upon HIV infection. We will explore therapeutic strategies
to reduce PMN-MDSC and prevent T-reg expansion upon HIV infection in vivo. The knowledge gained from our
work will facilitate new insight into the mechanisms that control or exacerbate HIV-infection-induced immune
disturbance and disease.

Public health relevance
Elevated frequencies of immunosuppressive myeloid cells precede and contribute to immune dysfunction in persons living with Human Immunodeficiency Virus; however, the underlying mechanisms of this dysregulation are poorly understood. Our studies will leverage novel tools and therapeutic approaches to reduce immunosuppressive myeloid cells upon HIV infection. The knowledge gained from our work will facilitate new insight into the immune mechanisms that control or exacerbate HIV-infection-induced immune disturbance and disease.